Impact of Clot Histological and Physical Properties on Revascularization Strategies in Acute Ischaemic Stroke

PROJECT SUMMARY
The long-term objective of this research program is to improve the care of patients suffering from acute
ischemic stroke secondary to large vessel occlusion. Acute ischemic stroke affects up to 700,000 people a
year in the United States and is the fourth leading cause of death. Approximately 10% of acute ischemic
stroke patients present with large vessel occlusion which are associated with high rates of long-term morbidity
and mortality. As of 2015, mechanical thrombectomy became standard of care for treatment of acute ischemic
stroke from large vessel occlusion. Since then, there has been a significant increase in the use of mechanical
thrombectomy for acute stroke treatment.
Despite high revascularization rates (~80%), 50% of stroke patients still experience poor neurological
outcomes. In addition, 20% of patients are not successfully revascularized due to limitations of current
revascularization technologies. Rates of clot fragmentation during mechanical thrombectomy are high with
most patients having residual tiny distal emboli in the ischemic territory and up to 10% of patients developing
emboli in previously unaffected vascular beds due to fragmentation during clot retrieval. High rates of clot
fragmentation and failure to remove the clot resulting in poor neurological outcomes suggest that in order to
further advance the field of stroke intervention, we must turn our attention to the science of clot.
In this R01 program we will embark on a comprehensive study of the histological, physical and imaging
characteristics of clot in acute ischemic stroke with the ultimate goal of studying the efficacy of various
revascularization strategies on different clot phenoytpes so that care of acute ischemic stroke patients can be
improved. We propose a methodical approach to the study of clot in stroke. Our first aim is to characterize the
histological characteristics of clots from a large sample of acute ischemic stroke patients from multiple
institutions. Data from this registry will then be used to 1) identify clot phenotypes which will be made for
further in vitro study and 2) identify histologic characteristics that are more commonly present in clots prone to
fragmentation or difficult to remove clots. Our second aim is to identify imaging biomarkers to identify difficult
clots by performing in vitro imaging of the clot phenotypes identified in the first aim. Our third aim is to
determine which revascularization techniques are associated with superior outcomes when treating each clot
phenotype. This will be performed using an in vitro flow model which replicates the physiological conditions of
acute ischemic stroke in humans. If successful, this translational research program will directly improve patient
outcomes by helping the stroke community better identify difficult to treat clots and provide data on which
revascularization techniques are best suited for clots which are prone to fragmentation or difficult to remove.

Public health relevance
PROJECT NARRATIVE Acute ischemic stroke affects up to 800,000 people per year in the United States and is the fourth leading cause of death. Mechanical thrombectomy has become standard of care for acute ischemic stroke secondary to large vessel occlusion and up to 70,000 of these procedures will be performed annually by 2020. Despte best practice, 20% of stroke patients receiving mechanical thrombectomy do not get revascularized and among those who are revasularized, nearly 30% have distal emboli secondary to clot fragmentation. The goal of this project is to identify the histologic characteristics of clots which are more prone to fragmentation or more difficult to remove, develop imaging biomarkers to identify these difficult clots and identify the best thrombectomy techniques to achieve complete revascularization for these clots.